Shared Resource: Research Pathology

PROJECT SUMMARY: RESEARCH PATHOLOGY SHARED RESOURCE (RPSR)
The Research Pathology Shared Resources (RPSR) provides a suite of cutting-edge tools to enable the
analysis of complex cancer phenotypes in a spatially-resolved manner. Understanding the complex pathologic
“social network” within tumors is essential to further develop our mechanistic understanding of cancer and
translate those learnings into effective cancer treatments. The RPSR offers capabilities ranging from routine
histopathology services to custom immunohistochemical antibody and assay development to cutting-edge
multiplex immunohistochemistry (mIHC). In addition, the RPSR Lab Directors and staff scientists provide wide-
ranging expertise, extending from the experimental design phase to downstream quantitative image analysis.
The RPSR is committed to fostering a culture of continuous improvement and providing innovative, high-
quality, cost-effective and expeditious services to the Fred Hutch/University of Washington Cancer Consortium
in order to broadly contribute to the basic and translational mission of the Consortium.

Public health relevance
Not applicable to P30 CCSG as stated in the FOA PAR-17-095.